SHORT TERM CONSISTENENCY OF ADVANCE DIRECTIVES

This is a study to evaluate the stability of instructions about life-sustaining treatments in a well, elderly population. Subjects will be asked their wishes about four treatments (attempted CPR, artificial feeding, mechanical ventilation, antibiotics) in two scenarios (current function and advanced dementia). This process will be repeated at Day 14, Day 28 and one year later.